Chromosome 1q ceRNAs in Melanoma Progression and Metastasis

PROJECT SUMMARY – Per Parent Award R01CA259046
Metastasis is the main cause of deaths related to malignant melanoma. Studies over the last decade have
revealed that the metastatic process is not primarily driven by genetic changes. Instead, deregulation of gene
expression through epigenetic, transcriptional, or posttranscriptional mechanisms as well as copy number
alterations may promote melanoma metastasis. Our previous work described how messenger RNAs engage in
protein coding-independent posttranscriptional regulation by sequestering microRNAs (miRNAs) from other
transcripts, and we termed such natural miRNA sponges competitive endogenous RNAs (ceRNAs).
Deregulated ceRNA expression has been causally linked to cancer development, and thus genomic copy
number gains of ceRNA genes may be an important driver of malignant progression of melanoma. We have
identified a cluster of melanoma ceRNA genes localized on chromosome 1q, which undergoes copy number
gains (1qGAIN) in 25-50% of melanoma. 1qGAIN is more frequent in metastases, suggesting that 1qGAIN ceRNAs
may contribute to melanoma progression. Our predictions identified CEP170 as a potent 1qGAIN ceRNA, and
preliminary experiments revealed its oncogenic role in vitro and in vivo. Two additional 1qGAIN ceRNAs,
NUCKS1 and ZC3H11A, exhibited oncogenic potential and enhanced the CEP170-mediated effects. Thus,
gains of 1q may lead to overexpression of multiple ceRNAs that promote melanoma metastasis by
sequestering tumor suppressive miRNAs. We have identified five metastasis-associated miRNAs that are
sequestered by CEP170 and that promote melanoma cell migration and invasion. In this proposal, we will
systematically examine the oncogenic role of 1qGAIN ceRNAs in melanoma metastasis. Specifically, in Aim 1
we will examine if the 3’UTR of CEP170 promotes melanoma dissemination in a miRNA binding site-specific
manner using metastasis and autochthonous models. In Aim 2 we will assess if the release of miRNAs from
the endogenous CEP170 transcript opposes metastasis, and if these miRNAs have tumor suppressive activity
in melanoma cells. Moreover, we will identify and characterize downstream effectors that mediate the CEP170-
provoked phenotype. Finally, in Aim 3 we will examine if NUCKS1 and ZC3H11A boost the effect of CEP170
by augmenting miRNA sequestration. We will also test if any of the remaining 1qGAIN ceRNAs, ten in total,
possess oncogenic activity and cooperate with CEP170. We expect that our study will reveal the biological
relevance of 1qGAIN ceRNAs to melanoma metastasis and further elucidate the mechanisms underlying ceRNA-
mediated melanoma progression and metastasis.

Public health relevance
PROJECT NARRATIVE – Per Parent Award R01CA259046 Non-genetic changes in gene expression promote melanoma progression and metastasis; however, whether aberrant miRNA sequestration by competitive endogenous RNAs (ceRNAs) is involved in this process is unknown. We have discovered a cluster of ceRNA genes located on the frequently gained chromosome 1q region, and found that the mRNA with the greatest predicted ceRNA potential, CEP170, promotes melanoma migration/invasion in vitro and metastasis in vivo. We propose to define the miRNA-dependent oncogenic potential of CEP170 and characterize how the deregulation of downstream miRNAs and ceRNA effectors provokes melanoma metastasis.